Administrative Core

The goals of the Administrative Core are to provide the leadership of the CCMBM program, and the management of the Research Core Facilities and Enrichment Program. The CCMBM leadership represents the two flagship Departments of the CCMBM (Orthopaedic Surgery and Internal Medicine, Division of Bone and Mineral Diseases) and reflects the commitment of the two Departments to the mission of this program and to musculoskeletal research at Washington University. The CCMBM has three Research Cores that provide top-quality services to members of our Research Base and to other investigators at Washington University and other institutions with interest in musculoskeletal research. In the next five years, we plan to continue providing top-quality services to our Research Base and other investigators, while developing new cutting-edge technologies and programs, hinging upon the expertise and experience built in the past four years of activities. As a new direction, we will address an area of relative underachievement, i.e. the interaction between basic and clinical researchers, with the purpose of facilitating translation of basic and animal research to the clinic for the ultimate benefit of patients with musculoskeletal disorders. The specific aims of the Administrative Core for the next five years are: Aim 1 - Provide Leadership of the CCMBM, and Integrate Core Center Components and Activities Aim 2 - Administer the Center Enrichment Program including a Pilot and Feasibility Grant Program, Musculoskeletal Seminar Series and Summer Educational Series, Annual Symposium and Holiday Party and Poster Session Aim 3 - Communication with stake holders (E-Newsletter, Website) Aim 4 - Coordinate Core Center Activities with other Programs including a mentoring program with the T32 Metabolic Skeletal Disorders Training Grant, Institute for Clinical & Translational Science, Center for Regenerative Medica and over Washinton University Core Facilities Aim 5 - Promote Awareness and Exchange Information on the Translation of Research

Public health relevance
Musculoskeletal disorders and metabolic diseases will effect almost 100% of people in the United States. Our Musculoskeletal Research Center, with the help of the NIH, has become a premier research center. We provide a range of research technologies to investigate some of the most common musculoskeletal diseases such as osteoporosis, osteoarthritis and tendon and ligament injuries.